Systemic Corticosteroid Pharmacokinetics and Pharmacodynamic Biomarker Identification in Children with Asthma and Obesity

Project Summary
The overall goal of this 5-year K23 proposal is to support Dr. Kathryn Kyler to become an independent
investigator in the field of pharmacokinetic (PK) modeling and pharmacodynamic (PD) biomarker development
for children with asthma and obesity. This proposal aligns with the NHLBI’s Precision Medicine Initiative, as
well as prioritization of obesity related research in relevant diseases like asthma. The proposal also aligns with
the NIH Better Pharmaceuticals for Children Act which has named PK/PD studies focused on children with
obesity as a priority. Children with asthma and obesity have a distinct asthma phenotype and endotype,
characterized by more severe asthma than those without obesity (e.g., more exacerbations, hospitalizations),
and different baseline inflammatory patterns (i.e., elevated IL-6 and TNF-) than asthmatic children without
obesity (i.e., allergic-type inflammation). It is currently unknown how these differences modulate drug exposure
and response for medications like systemic corticosteroids (SCS) used to treat asthma exacerbations. This
career development proposal will leverage Dr. Kyler’s expertise as a pediatric hospitalist and clinical
pharmacologist-in-training to expand her skills in clinical and translational PK/PD study methods, enabling her
to define obesity’s effect on SCS dose-exposure-response relationships. The comprehensive career
development plan contains three training objectives to improve Dr. Kyler’s skills in: 1) advanced PK modeling,
2) PD biomarker development, and 3) pediatric clinical trial best practices. This plan includes structured
mentoring, didactic training, and experiential learning which will be applied to the following scientific aims: 1)
determine differences in SCS-mediated immune cell response in vitro across weight groups, 2) determine
differences in SCS exposure among asthmatic children with and without obesity, 3) evaluate the relationship
between SCS exposure and PD biomarkers. Dr. Kyler’s career development and research plans will take place
in an excellent environment which includes a tertiary academic children’s medical center, a pediatric research
institute, a multi-institutional Clinical and Translational Science Institute (CTSI), as well as access to experts in
fields directly related to both her training and scientific aims. After completing this project, Dr. Kyler will have
advanced the field of drug pharmacokinetics and dynamics in children with asthma and obesity and generated
data to support an R01 application to validate and test PK and PD model-informed SCS dosing strategies in
children with asthma and obesity. This work will position her to become a leader in the field of precision
therapeutics for children with asthma and obesity, able to link pharmacologic translational science to the
bedside for performance of pediatric clinical trials.

Public health relevance
Project Narrative Children with asthma and obesity have worse outcomes and poorer response to systemic corticosteroids (SCS) compared to lean children with asthma, but the pharmacologic mechanisms underlying these differences and their associations with obesity are poorly understood. The overall goal of this K23 proposal is to evaluate the effect of obesity on the SCS drug dose-exposure-response relationship by studying differences in SCS pharmacokinetics and pharmacodynamics between asthmatic children with and without obesity. At the completion of this proposal, Dr. Kathryn Kyler will be well-positioned for a career as an independent clinician- scientist focused on improving outcomes for children with asthma and obesity through development and evaluation of pharmacologic-evidence based drug dosing strategies.